Optimization of Marmoset Sperm Cryopreservation

Abstract:
The common marmoset (Callithrix jacchus) is emerging as an increasingly desirable nonhuman primate model
for many different biomedical studies, but animal numbers are limited creating a national shortage of high-quality
marmosets available for biomedical research. The availability of an optimized sperm cryopreservation protocol
will facilitate banking of gametes from each adult male so that it can then be used for other aspects of biomedical
research. Here we propose to develop, optimize, confirm and validate the utility of such a protocol. We will
optimize sperm collection method, sample dilution, cryoprotectant, extender, packaging, cooling/freezing
conditions, and thawing conditions. Optimization will be based on assessment of frozen/thawed sperm in
comparison with freshly ejaculated sperm for sperm count, viability, morphology, motility, sperm chromatin
status, RNA content, genomic integrity and epigenetic profiling. Utility of the optimized protocols will be based
on successful application at other marmoset centers. Successful optimization of a marmoset sperm
cryopreservation protocol will greatly enhance the utility of individual male marmosets, while also greatly
enhancing the ease and efficiency with which genetic diversity and/or specific genetic models can be distributed
throughout the country or beyond.

Public health relevance
Narrative: Marmosets are becoming increasingly popular for use as models for biomedical research. However, they are in short supply. This proposal seeks to optimize a protocol for cryopreservation and banking of marmoset sperm to help rapidly expand populations of marmosets in scientific centers, and to provide more efficient ways to increase genetic diversity and distribute valuable new genetic models.